EFFECTS OF SEROTONERGIC ACTIVITY ON NEUROENDOCRINE AND BEHAVIORAL MEASURES

Several studies suggest possible serotonergic involvement in the neurobiology of alcoholism and panic disorder. To evaluate this possibility we administered the serotonin agonist m-chlorophenyl piperazine (m-CPP) to alcoholics, alcoholics with panic disorder and controls. By observing the drug-induced behavioral effects and measuring changes in prolactin, cortisol and ACTH we hope to make inferences about post-synaptic serotonin function in these patient populations.